Society of Behavioral Medicine 2021 Annual Meeting & Scientific Sessions

PROJECT ABSTRACT The Society of Behavioral Medicine (SBM) will hold its 42nd Annual Meeting & Scientific Sessions April 12-16, 2021. This meeting will be entirely virtual due to the COVID-19 pandemic. This application seeks funding in support of meeting programming addressing the following specific aims: (1) to train attendees in the skills necessary to meaningfully include diverse voices in their research and practice (e.g., inclusion of racial/ethnic and gender minorities; cross-disciplinary collaboration; involvement of industry and community partners) to improve individual and population health as well as persistent, systemic health inequities; (2) to showcase innovative models for identifying and promoting health solutions, including via influencing policy and public discourse; and (3) to enhance the diversity of behavioral medicine professionals by providing mentoring, leadership training, professional development, and networking opportunities to trainees, junior and mid-career faculty, clinicians, industry professionals, and others who attend the meeting. SBM is the nation’s leading scientific society dedicated to behavioral medicine, representing approximately 2,400 researchers and clinicians from more than 20 disciplines. SBM’s members include researchers, clinicians, educators, and industry professionals who focus on the development and integration of behavioral, psychosocial, and biomedical theory, knowledge, and interventions relevant to the understanding of health and disease. They work to understand, prevent, and treat chronic diseases such as cardiovascular diseases, respiratory diseases, diabetes, and cancer. They conduct research and translate findings into real-world settings to improve lives while also reducing healthcare costs. SBM’s annual meetings are the premier forum for disseminating behavioral medicine’s important ideas and breakthroughs. The meeting’s educational sessions, networking events, and interactive research spotlights facilitate exchange of information and ideas. Attendees apply the knowledge gained to disease prevention and management, and development of innovative research designs, effective interventions and strategies, and evidence-based policies. An estimated 3,000 individuals from the United States and abroad will attend the 2021 SBM Annual Meeting, which will feature more than 1,500 presentations. The meeting theme is “Let’s Go All In: Inclusion, Innovation, Influence.” We must be inclusive in our efforts to train and develop a diverse biomedical workforce and in our decision-making. We must be innovative in our efforts to identify and promote health solutions, especially to those with greater burden. We must continuously seek opportunities to influence policies and practices so they are evidence- and inclusion- based. Sessions will energize attendees to use meaningful inclusion to better innovate and exert influence to tackle health pervasive problems and health inequities using evidence-based behavioral medicine. Most of our country's health challenges have behavioral origins. Behavioral medicine and the evidence it generates are more important than ever.

Public health relevance
PROJECT NARRATIVE (PUBLIC HEALTH RELEVANCE) The Society of Behavioral Medicine’s 42nd Annual Meeting & Scientific Sessions, to be held virtually April 12- 16, 2021, will bring together 3,000 of the nation’s leading behavioral scientists, clinicians, educators, and policymakers to exchange new research on improving health through behavior change, in particular via using meaningful inclusion to better innovate and exert influence. Through a broad range of scientific presentations, discussions, and skill-building workshops, the meeting will facilitate the exchange of the latest population‐level, clinic‐based, and experimental research on the prevention and treatment of the leading causes of morbidity and mortality, with the goals of improving health behaviors, reducing the burden of chronic disease, improving health inequities, lowering healthcare costs, and bettering our nation’s health.